Function and regulation of heterotrimeric G proteins in ciliogenesis and pathobiology of neurodevelopmental disorders

PROJECT SUMMARY
Many components of G-protein-coupled receptor (GPCR) signaling including heterotrimeric G (abg)
proteins localize to primary cilia and modulate their morphology. Although cilia defects and dysregulated G
protein signaling are associated with neurodevelopmental disorders (NDDs), the mechanisms by which G
proteins regulate cilia morphogenesis or the extent to which disruption of ciliary Ga signaling contributes to NDDs
remain largely unknown. The overall objective for this proposal is to define the molecular mechanisms by which
RIC-8 – a highly conserved GPCR-independent activator of Ga proteins – shapes cilia morphology in sensory
neurons. The overarching hypothesis for this application is that RIC-8 is dynamically trafficked to sensory cilia
and controls ciliogenesis by potentiating Ga signaling. This hypothesis will be tested by pursuing two specific
aims. Under the first aim, in vivo protein interaction assays and genome editing approaches will be used to
mechanistically define the functional role of the RIC-8-Gai/o axis in controlling cilia morphogenesis. For the
second aim, a synergistic approach comprised of genetic, imaging and in vivo proteomic approaches will be
applied to identify molecular regulators of RIC-8 ciliary transport and function in sensory neurons. The proposed
research is innovative because it uses a comprehensive approach to define a novel cellular function of RIC-8-
Gai/o signaling in neuronal development. The proposed research is significant because it is expected to establish
a strong scientific framework for investigations into the molecular composition and functions of the ciliary RIC-8-
Gai/o signaling network(s) in C. elegans and vertebrate models and to determine how altered Ga-protein signaling
may contribute to neurodevelopmental disorders.

Public health relevance
PROJECT NARRATIVE Primary cilia extend from the surface of most human cells, and their disruption leads to a myriad of genetic disorders. The proposed research is relevant to public health because its goal is to define the role of a conserved signaling axis in cilia morphogenesis during neuronal development. A complete understanding of molecular mechanisms behind neuronal cilia assembly and function has the potential for development of new therapeutic options for neurodevelopmental disorders.